Imaging Core

The goal of the Imaging Core is to provide state-of-the-art, customized image acquisition, reconstruction,
and quantitative analysis for pre-clinical (tissue samples and animal models) and in vivo human
musculoskeletal research. These will include pre-clinical and clinical: 1) acquisition and reconstruction of
MRI/MRSI, PET, SPECT, CT, and optical tomography data; 2) spatial registration of multi-modality images; 3)
extraction of quantitative information concerning biologically relevant image parameters; and 4) evaluation of
the relationships of these imaging-derived parameters to biochemistry, histology, biomechanics, and
physiology of biological systems interacting with the musculoskeletal system. Many of these procedures are
novel and require specialized knowledge of imaging physics and mathematics. Investigators linked to the
Imaging Core have extensive experience in these imaging and quantitative analysis techniques and will work
closely with CCMBM investigators to match and/or develop the best imaging and data processing methods to
their specific research questions.
Innovation and Service:
Aim 1: To develop, maintain, and support state-of-the-art quantitative image acquisition and
reconstruction methods for pre-clinical and human musculoskeletal tissues.
Aim 2: To develop novel image grading and quantitative analysis and to provide templates, training, and
implement robust measures for clinical grading of radiographs, CT and MR images, and software
packages for post-processing, visualization, and quantitative analysis.
Aim 3: To provide interpretation of imaging data from single and serial imaging examinations and assess
links to biochemical, histological, and biomechanical measures that are extracted and the relevant clinical
or experimental endpoints.
Education and Dissemination: The overarching goal will be to promote development and adoption of state-of-
the-art imaging methodology in musculoskeletal research.
Aim 4: To provide web portal access to examples of previous studies that have used imaging endpoints
and detailed descriptions of clinical and research imaging services, and to handle new service requests
efficiently though the web portal.
Aim 5: To perform proactive outreach to attract potential new users and participate in CCMBM seminar
activities to provide imaging seminars, workshops, and facilities tours that will introduce new imaging and
image processing capabilities to the CCMBM community, with particular focus on junior and early stage
investigators.

Public health relevance
PROJECT NARRATIVE Not Applicable